Characterizing extracellular glycoproteins and unraveling their functions

Abstract
Proteins on the cell surface and in the secretome play extremely important roles in nearly every extracellular
event from cell-cell communication to cell response to environmental changes. Almost all of them are
glycosylated, and aberrant expression and interactions of extracellular glycoproteins are directly related to
human diseases such as cancer. Both the protein part and the glycan component contain much valuable
information about cellular developmental and diseased statuses. Secreted glycoproteins in the bodily fluids
provide an excellent non-invasive source for disease early detection, and besides serving as biomarkers, surface
glycoproteins are often drug targets, especially for macromolecular drugs such as antibodies and enzymes.
Comprehensive characterization of extracellular glycoproteins can help better understand protein functions,
cellular activities, and disease mechanisms. However, it is extremely challenging because of the low abundances
of many glycoproteins, the high diversity of glycans, and the complexity of biological samples. Besides these
challenges, the methods are required to selectively separate glycoproteins on the cell surface or in the secretome
prior to mass spectrometric analysis. Furthermore, the interactions between surface glycoproteins and secreted
ones are essential for cell-cell communication and cell immune response, but remain to be explored. There is
an urgent need to develop innovative methods to systematically study extracellular glycoproteins and their
interactions. Based on extensive research experience with mass spectrometry (MS)-based glycoproteomics,
novel and effective methods will be developed to comprehensively analyze glycoproteins on the cell surface and
in the secretome. Furthermore, a new and integrative method will be developed to systematically investigate the
interactions between surface glycoproteins and secreted ones from other cells, which will provide unprecedented
and valuable information, including identifying new ligands for orphan receptors and discovering novel
interactions between surface proteins and secreted ones. Additionally, the regulation of glycans on the
interactions among extracellular glycoproteins will also be studied. These methods will be applied to study
extracellular glycoproteins and their interactions in different types of immune cells with bacterial or viral infection.
Considering the importance of extracellular glycoproteins, the proposed methods in this project will have
extensive applications in the biological and biomedical research fields.

Public health relevance
Narrative: The proposed research is relevant to public health because extracellular glycoproteins play extremely important roles in human diseases such as cancer and infections, and the proposed methods will help comprehensively characterize extracellular glycoproteins. It will advance the understanding of protein functions and disease mechanisms, leading to the discovery of glycoproteins as effective biomarkers for disease detection and novel drug targets for disease treatment. Thus, the proposed research is relevant to the portion of NIH’s mission that pertains to seeking fundamental knowledge that will enhance health, lengthen life, and reduce disability.